Alliance to Disseminate Addiction Prevention and Treatment (ADAPT): A Statewide Learning Health System to Reduce Substance Use among Justice-Involved Youth in Rural Communities.

PROJECT SUMMARY
Indiana ranks 14th nationally in drug overdose deaths and, from 2016 to 2017, experienced the 3rd largest
increase (22.5%) in overdose deaths. The CDC recently reported Indiana as one of only six states with a
significant increase in emergency department visits for suspected opioid overdose. Yet, Hoosiers at risk for
opioid misuse and other substance use disorders (SUDs) are unlikely to receive necessary services; Indiana -
a largely rural state - ranks 46th in number of behavioral health treatment providers per individuals suffering
addictions. By targeting rural counties in a Midwest state, our research team seeks to address the national
opioid crisis at its epicenter. We will also focus on a population among those at greatest risk for opioid-related
harms: youth involved in the juvenile justice system (YJJ). Among arrested youth, 78% have recently used illicit
substances. Our research has shown that YJJ die at 1.5 times the rate of youth who have never been arrested,
and a leading cause of YJJ death is drug overdose. The primary goal of our proposed project, Alliances to
Disseminate Addiction Prevention and Treatment (ADAPT), is to address barriers to effective SUDs treatment
of YJJ as identified by the substance use care cascade. We will accomplish our goal by creating alliances
between the juvenile justice system (JJ) and community mental health centers (CMHCs) in 10 rural Indiana
counties. These collaborative JJ-CMHC partnerships will facilitate SUD risk identification and service
connection by JJ and enable timely initiation and engagement in evidence-based SUD treatment provided by
CMHCs. ADAPT takes a two-pronged approach. First, we will employ a Learning Health System (LHS) model
to develop alliances between JJ and CMHCs. Second, we will maximize opioid use prevention efforts by
implementing a bundled treatment approach to improve screening, resource allocation, workforce development
and evidence-based interventions (EBIs) that target a range of SUD risk levels. We hypothesize that ADAPT –
a combination of the LHS alliances and dissemination of targeted SUD EBIs – will positively affect SUD and
recidivism outcomes over time. We will conduct a hybrid type II comparative effectiveness, cluster randomized
clinical trial to compare the LHS to the EBI interventions. In addition, we will employ sophisticated
methodology, such as a sequential multiple assignment randomized trial (SMART) design, and leverage our
expertise in linking administrative data from multiple health and justice systems, to assess these outcomes. We
will utilize our expertise in implementation science, community-based research, clinical trials, cost-
effectiveness research, and linking administrative databases, for research to assess the impact of these
interventions on criminal recidivism and substance use outcomes, including transition to opiate use disorders
and opiate overdose. We expect this project will guide future community-based efforts targeting the substance
use care cascade among vulnerable populations.

Public health relevance
Through this project, we seek to improve collaboration between juvenile justice settings and community mental health centers. We will test two interventions, one focused on continuous quality improvement and one focused on helping community mental health centers target effective substance use services more accurately for youth involved in juvenile justice. We recognize the cultural and climate of both institutions impacts this work and we will assess changes over time.